Molecular and Cellular Biophysics Training Grant

Abstract
The University of North Carolina (UNC) Molecular and Cellular Biophysics Program (MCBP) is a successful
interdisciplinary graduate training program with three essential goals: 1. To attract a diverse cohort of talented
post-graduate students to apply the methods and concepts of the quantitative and mathematical sciences to
problems in biology; 2. To provide a flexible vehicle for training this diverse group of graduate students who
share with our biophysics faculty a commitment to developing molecular level descriptions of complex biological
systems and processes; 3. To foster interactions and enhance the training and research environment within this
diverse group of faculty and students. In the previous funding period we achieved a number of important goals
including transition to new leadership, successful establishment of MCBP as an official UNC Certificate Program,
the development of a new “Computational Biophysics Track”, and the continued recruitment of well-qualified
Trainees. This application is for continued funding of this successful training program in an area critical to
biomedical research. In addition to maintaining a wide range of program activities, in the next grant period we
will focus on three specific aims: 1. Expand the curriculum to offer training in cryo-electron microscopy and
familiarize students with resources in fabrication; 2. Enhance training in ethics and rigor and reproducibility while
strengthening our community; 3. Improve faculty mentoring skills through a new mentoring workshop sponsored
by the UNC School of Medicine.

Public health relevance
Project Narrative Biophysics is an interdisciplinary field of the biomedical sciences that aims to understand the mechanisms of human health and disease on a molecular scale using the tools of the physical and quantitative sciences. The Molecular and Cellular Biophysics Program (MCBP) at the University of North Carolina at Chapel Hill is an established and highly successful training program in biophysics that seeks refunding in order to train students for this rapidly advancing and critical field.